EHR-based patient safety: Automated error detection in neonatal intensive care

DESCRIPTION (provided by applicant): In the field of neonatal patient safety, the paucity of systematic research is a critical barrier to progress. Notably missing are studies that meticulously investigate Electronic Health Records (EHR) and information technology in detecting neonatal intensive care-related errors. The expert panel at the National Institute of Child Health and Human Development (NICHHD) identified multiple gaps in the current knowledge of neonatal patient safety research. The proposed work is a well focused response to three dimensions of the Funding Opportunity Announcement: 1.Develop prospective and retrospective study designs to collect data on patient safety and adverse events. 2.Study the strength and limitations of current methods of error reporting systems. 3.Study the usefulness of commercial IT systems and EHRs in reducing medical errors. In our study we seek to shift patient safety research toward an automated and computerized approach to achieve a more comprehensive patient safety paradigm. We will develop novel Electronic Health Record (EHR) content-based automated algorithms that are new to patient safety research to 1) detect errors (Aim 1) and 2) categorize subsequent harm (Aim 2). State of the art information extraction and statistical classification techniques from the field of clinical Natural Language Processing (NLP) will be adapted to the patient safety research tasks. In Aim 1 we will fill the gap in the literatre by implementing a focused manual review of 700 charts (one full year of patient admissions at our institution) in one of the largest Neonatal Intensive Care Units (NICU) in the nation. Using a trigger tool, we will identify errors occurring in three specified categories - laboratory test errrs, medication/fluid errors, and airway management errors. We will develop novel algorithms for automated EHR-based detection of the errors and evaluate the performance of the new algorithms against the performance of both trigger tool review by human chart reviewers (current gold standard) and the voluntary incident reporting system (accepted standard). In Aim 2, we will study the utility of novel EHR-based information extraction and statistical algorithms for the automated categorization of errors according to the resulting level of harm. Our proposed work has the potential to accomplish a paradigm shift in the methods of neonatal patient safety research and practice. The study is a fundamental step to automating patient safety monitoring on a large scale and improving error identification and patient safety in NICUs for millions of children every year.

Public health relevance
We are developing an automated error detection technique to improve the safety of newborn babies during hospital care. Our work is the first known attempt to use text analysis in the electronic health records on a large scale to reduce the cost while at the same time increase the speed and comprehensiveness of error detection in the clinical care of newborns.